Multiscale Computational Modeling of Myocardial Hemodynamics, Oxygen Transport, and Autoregulation in Health and Disease

Project Summary/Abstract
Myocardial hemodynamic function is heavily influenced by intramyocardial pressure which increases during
systole and is highest in the subendocardial region. The complex interaction between myocardial tissue and
vasculature leads to unique hemodynamic phenomena in the myocardium including vascular compression
during systole in the subendocardium, diastolic-dominant arterial blood flow, bouts of retrograde arterial flow
during systole, and systolic dominant venous flow. Vasoregulation, adjusting the diameter of blood vessels
through the constriction or relaxation of smooth muscle cells in vessel walls, can alter myocardial
hemodynamics and help match oxygen delivery to myocardial oxygen demand. Currently, there exist
numerous hypotheses regarding how the biomechanics of myocardial hemodynamics and physiological
vasoregulatory responses must operate in order to supply sufficient oxygen to all areas of the myocardium.
The overall goals of this project are to develop comprehensive computational models of myocardial
hemodynamics and oxygen perfusion that incorporates vasoregulatory mechanisms and to use these models
to test hypotheses on the mechanisms governing transmural variation of hemodynamics and oxygen perfusion.
Key model constituents will include: 1) anatomically realistic arterial, capillary, and venous networks; 2)
temporally varying inlet arterial pressure and temporally and spatially varying transmural pressures; 3) high-
fidelity oxygen transport at the capillary scale. Models will be identified and validated based on data from in
vivo and in vitro experiments through an ongoing collaboration between research groups at the University of
Michigan and University of North Texas. The integrated model, in turn, will be used to analyze results, make
novel predictions, develop and refine new hypotheses, and design new experiments.

Public health relevance
Project Narrative Current understanding of the processes governing blood flow and oxygen delivery to the muscle of the heart is insufficient. The goal of this project is to create comprehensive computer models, based on experimental data, that simulate these processes. These computer models will be used to test hypotheses about how blood flow in the heart is regulated as well as explore why certain regions of the myocardium, such as the endocardium, are at an elevated risk of ischemia.